Mechanisms of liver metastasis and associated resistance to immunotherapy

PROJECT SUMMARY
Cancer immunotherapies have revolutionized the therapy of many cancers, including metastatic
melanoma and clear cell renal cell carcinoma (ccRCC). Dating back 30 years, the first cancer
immunotherapy, high-dose interleukin-2, was successfully tested in melanoma and ccRCC and
provided a first proof-of-concept of a transformative therapeutic potential.1-3 In the last decade,
melanoma and ccRCC have represented archetypical diseases, in which a portion of patients
experience durable responses to novel immunotherapies, such as immune checkpoint inhibitors
(ICI), and these observations frequently extrapolated to other cancers as well (e.g., lung cancer).
4-8 However, most patients do not response to ICI and the underlying mechanisms are unclear.
In our initially funded grant (R37CA258829), we explore the role of liver metastasis and their role
in conferring resistance to ICI, both locally and in concurrent metastatic sites (e.g., lung
metastases). We leverage cutting-edge models and technologies, including single-cell genomics,
to dissect this clinically relevant predictor for ICI resistance, and explore opportunities for pre-
clinical testing of combination therapies that may help overcoming resistance to ICI. In the current
proposal, we will expand on these initial studies and study molecular predictors of response and
resistance in patients with metastatic ccRCC who are treated with a combination of ICI and
inhibitors of vascular endothelial growth factor receptors (VEGFR). For this purpose, we have
collected paired snap-frozen tissue specimens from patients before therapy and after a course of
ICI and VEGFR inhibitor therapy. In preliminary studies, we applied cutting-edge technologies
developed in our laboratory to enable multi-modal single-cell genomics from frozen tissues
achieving excellent technical quality. Furthermore, we established panels for multiplexed
immunofluorescence (mIF) on matching tissues. In Aim 1, we will perform mIF on determining
spatio-temporal effects of ICI + VEGFR inhibitor therapy, and correlate changes in immune
infiltrates with clinical outcomes. In Aim 2, we will perform multi-modal single-cell genomics,
including RNA-sequencing and T cell receptor sequencing (TCR) to determine both cancer cell
intrinsic and extrinsic molecular and clonal correlates of response and resistance at single-cell
resolution. Together with the proposed work in the initial grant application, this supplement will
further enhance our understanding of molecular and cellular correlates of response and
resistance to immunotherapies.

Public health relevance
PROJECT NARRATIVE Cancer immunotherapies have revolutionized the care of patients with a variety of advanced cancers, including patients with melanoma and clear cell renal cell carcinoma (ccRCC). While some patients experience durable responses, most do not. The mechanisms of resistance to cancer immunotherapies are poorly understood and may involve clinical features (e.g., the presence of liver metastasis) or molecular features within the tumor or tumor-microenvironment. Combination therapies may provide a strategy to overcome drug resistance. Here, we will use cutting-edge technologies to study malignant cell states and the tumor-microenvironment in patients undergoing combination therapies.